J. NRSA Training Core

Contact PD/PI: REIS, STEVEN E NRSA-Training-001 (042)
Project Summary / Abstract
The purpose of the University of Pittsburgh TL1 Clinical and Translational Science (CTS) Fellowship Program
is to provide rigorous individualized training that encompasses core competencies in translational research
methodologies and interdisciplinary professional skills. We will support the career goals of fellows through an
intensive program of mentoring, scholarly activities, and career coaching. Over the past fifteen years, we have
built an extensive infrastructure of career development and degree programs tailored to educate and train
investigators at every stage of the career pipeline and across the spectrum of translational science. Our
commitment to mentoring as an integral part of career training has resulted in well-established mentoring
programs and an expansive pool of experienced senior investigators willing to serve as mentors to trainees and
students. We also provide trainees access to extensive statistical, ethics, data management, design, analytic and
editorial resources to further support their pilot research projects and grant proposals. For the CTS Fellowship,
we will draw fellows and faculty mentors from the six Schools of the Health Sciences, as well other schools such
as Engineering, Social Work, and Computing and Information. In addition, we are collaborating with 18
Minority Serving Institutions who send fellows to the University for training. We will utilize the more than 80
institutes and centers at the University that serve as hubs for multidisciplinary research. The immediate
objectives of this TL1 CTS Fellowship are to: recruit outstanding fellows; train fellows in rigorous research
methods; build skills in team science, leadership, stakeholder engagement, and entrepreneurship; guide fellows
in asking important translational research questions and implementing research projects; ensure close
monitoring of fellows to guide their research career development; and offer growth-mindset resilience training
and assist them in building work-life integration. Through rigorous methodological training and productive
research, we aim to shorten the time to independence for fellows by providing them with the foundation for
successful career development awards. Our long-term objectives are to ensure that fellows complete their
translational research studies on schedule, disseminate their research widely, and are positioned for sustained
translational research careers with impact. Our goal is to recruit a diverse pool of fellows, support them
throughout their career, and evaluate and track their success over time.